CLINICAL STUDIES IN THE ROLE OF PARATHYROID HORMONE ON UREMIC SYNDROME

The purpose of this study is to evaluate the effects of reduction of serum PTH by treatment with I.V. 1,25(OH)2D3 or of blocking the action of PTH with a calcium channel blocker.